USE OF PCR TO PREDICT DEVELOPMENT &RELAPSE OF OPPORTUNISTIC INFECTIONS

Summary of Work: In patients with HIV and other immunosuppressive diseases, one strategy for preventing infectious processes has been chemoprophylaxis or long-term suppression. However, drug toxicity and the development of pathogen resistance has made this approach less attractive, as has the complexity of resulting drug regimens. Another approach would be the early detection of infection in serum or buffy coats by polymerase chain reaction (PCR) for pathogens such as Mycobacterium avium/ intracellulare complex (MAC), cytomegalovirus (CMV), Mycobacterium tuberculosis, Pneumocystic carinii, and perhaps others. PCR is being adapted for rapid screening. Initial efforts will involve CMV and MAC. Laboratory samples are being tested and quantitative standards developed. A second stage of development will involve human samples. A third stage will involve prospective monitoring of patients. This strategy is a major change from the current emphasis on expensive and toxic drugs that are difficult to comply with. Proper probes, sample types, and populations need to be defined.